Defining roles for NTS Eya1 neurons in sickness and satiety

PROJECT SUMMARY/ABSTRACT
Specialized neurons in the nucleus of the solitary tract (NTS) receive and integrate gastrointestinal
signals of ingestion along with other relevant interoceptive parameters (e.g., gut irritants and infection) to
restrain food intake. NTS neurons that respond to gut irritants or systemic infection promote nausea associated
behaviors and sickness responses, and consequently reduce food intake; NTS neurons that track ingestion
restrain food intake to promote satiety. It is important to understand the specific types of NTS neurons that
respond to these distinct stimuli, and disentangle NTS neurons that promote satiety from those that promote
nausea or sickness responses. The broad goal of this proposal is to understand how systemic infection and
feeding converge on NTS neurons to reduce food intake.
The previous integration of mouse NTS snRNA-seq with human GWAS body mass index (BMI) data
predict that a novel NTS neuron population marked by expression of Eya1 (NTSEya1 neurons) plays crucial
roles in the control of food intake and body weight. In silico data from others predict NTSEya1 neurons may
promote sickness responses to lipopolysaccharide (LPS) administration, a model of systemic infection. To
understand the function and mechanisms of action for these cells, we generated Eya1Cre mice with which to
manipulate NTSEya1 neurons and test each in silico prediction. Our preliminary data suggest activating NTSEya1
neurons reduces food intake and body weight without promoting conditioned taste avoidance, a nausea
associated behavior. Silencing NTSEya1 neurons leads to hyperphagic obesity. In addition, these neurons are
activated in response to refeeding and LPS, suggesting that NTSEya1 neurons may restrain food intake in
response to two distinct stimuli. This proposal will test overall hypothesis that NTSEya1 neurons reduce food
intake and promote satiety without causing sickness responses.
To discover the physiological, and potential pathophysiological roles of NTSEya1 neurons, we will: (1)
Determine if activating NTSEya1 neurons are sufficient promote sickness responses, (2) determine if NTSEya1
neurons are necessary for the anorectic response to LPS, (3) define the structure of NTSEya1 neuron
projections and (4) identify the downstream projections of NTSEya1 neuron important to promote satiation.
At the conclusion of these studies, we will have defined the roles NTSEya1 neurons play in the control of
food intake, energy balance, and sickness responses. Thus, we will contribute to the broader understanding of
how brainstem systems integrate multiple interoceptive parameters to restrain feeding, potentially revealing
novel targets for the therapy of obesity.

Public health relevance
PROJECT NARRATIVE Obesity predisposes individuals to Type 2 diabetes in addition to a host of other complications. To identify new targets for the treatment of obesity, we must understand the systems that control food intake and body weight. This proposal will determine the mechanisms of action and roles for a novel set of hindbrain neurons that contributes to the suppression of food intake, and which may represent a target for obesity therapy.